ACQUISITION OF PERIPHERAL BLOOD STEM CELLS, PERIPHERAL BLOOD AND/OR BONE MARROW

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The study is to obtain normal healthy human peripheral blood stem cells, peripheral blood cells and bone marrow to support ongoing clinical research studies